Training Program in Adolescent Substance Use Disorders and Co-Occurring Mental and Behavioral Disorders

Project Summary
The NIDA T32 Training Program in Adolescent Substance Use Disorders and Co-Occurring
Mental and Behavioral Disorders, established five years ago, has become increasingly vital due
to rising youth mental health disorders and evolving substance use patterns. Rates of mental
health disorders in youth have increased and patterns of substance use have changed. Our
training mission aligns with the current U.S. Surgeon General’s focus on youth mental health and
NIDA’s Strategic Plan on training the next generation of scientists and accelerating research on
the interaction of substance use and related comorbidities. It also addresses the AAP-AACAP-
CHA’s declaration of a national emergency in child and adolescent mental health. Our program
has adeptly addressed training in the complexities of research on SUD, mental health disorders,
and how they co-occur. With a team of multidisciplinary research faculty, renowned for their
expertise in adolescent substance abuse and related mental health disorders, the program trained
9 predoctoral and 6 postdoctoral fellows from several disciplines. T32 graduates have procured
positions at top internship and training sites, as academic researchers, clinician researchers,
principal investigators of NIH-funded grants, and producers of high-quality empirical studies. The
renewal moves forward the program's comprehensive leadership, diverse training experiences,
administrative oversight, and continuous enhancement of trainee resources. The Training
Steering Committee, the External Advisory Committee, and exceptional Institutional Support have
played pivotal roles in maintaining high standards and updating the program to meet emerging
challenges in the field. Lessons learned from the initial funding cycle have led to a focus on training
15 predoctoral students from various related disciplines relevant to substance and mental health
in youth in the renewal. Each trainee, under the guidance of a Primary Mentor and supported by
Affiliated Faculty, will craft personalized training roadmaps through Individual Development Plans
that focus on four key domains: developmental psychopathology, preventive interventions and
dissemination, treatment and dissemination, and health services practices and implementation.
Relevant additional training in neuroscience and advanced statistics is incorporated into the
program along with robust training in in the responsible conduct of research and methods for
enhancing reproducibility. As we seek renewal, our vision is to serve as a national exemplar in
training the next generation of researchers in the intersection of substance use and adolescent
mental health. The renewed T32 program at FIU will further expand its impact, integrating novel
research methodologies and emerging trends in adolescent SUD and co-occurring disorders.

Public health relevance
Project Narrative In addressing the adolescent mental health crisis and changes in substance use patterns in youth, the T32 program at FIU remains focused in training on the complex interplay between adolescent substance use disorders (SUD) and co-occurring behavioral and mental health disorders in youth. Building on our initial success, the program will offer specialized training for predoctoral trainees to serve as future research leaders in adolescent mental health and SUD.